Choline-dependent metabolism in PNS myelination

ABSTRACT
Cells have a limited capacity to synthesize choline, thus cells depend
on protein transporters to import choline. Choline is used to synthesize
phosphatidylcholine, from which structural lipid components of myelin are
synthesized. Phosphatidylcholine is also metabolized to generate
phosphotidylinositols, whose phosphorylated derivatives are important
signaling lipids that regulate myelination. Choline is involved in synthesis
of the universal methyl donor, S-adenosylmethionine (SAM) for histone
and DNA methylation, thus regulating gene expression. Considering the
position of choline at the crossroad for the biosynthesis of phospholipids
and epigenetic regulation, we have very little to no understanding of the
regulation of choline import and choline-dependent metabolism in
myelinating glial cells. Choline transporter for Schwann cells has not been
identified.
We have identified choline-like-transporter 1 (CTL1) as an important
regulator of Schwann cell myelination. CTL1 deletion in Schwann cells
(CTL1sc-KO) results in early onset of focal hyper-myelination in the PNS.
Biochemical analysis revealed an overall decrease in choline-derived
phospholipids in the myelin. Furthermore, CTL1 loss impaired myelin
gene expression and exhibited altered DNA modifications in Schwann cells. From these observations, we
hypothesize that CTL1 is a Schwann cell choline transporter. We also hypothesize that choline-dependent
metabolism feeds into the phospholipid signaling and epigenetic modifications that are important for
myelination. To this end, we will investigate three aspects of choline metabolism in Schwann cell myelination.
Aim 1 will test the hypothesis that CTL1 is a Schwann cell choline transporter. MALDI-TOF and tandem
mass spectrometry will be performed to directly measure choline import into CTL1sc-KO Schwann cells.
Impact of CTL1 loss on phosphatidylcholine synthesis will also be analyzed. In Aim 2, we will test the
hypothesis that myelin defects in CTL1sc-KO mice results from imbalance in PI(3,5)P2 and PI(3,4,5)P3
synthesis. This is based on the observation that phosphatidylinositol contents are altered in CTL1sc-KO nerve
and the myelination defects resemble those seen in mice with dysregulated PI(3,5)P2 and PI(3,4,5)P3
synthesis. Aim 3 will test the hypothesis that CTL1 loss alters gene expression in Schwann cells by modulating
histone and DNA methylation.
Perturbed lipid metabolism, including choline, is an underlying mechanism in many hereditary diseases
associated with PNS myelination defects. Furthermore, dietary supplement of phospholipids has been
considered as a potential therapeutic option for treating PNS neuropathies. Therefore, results from this study
will provide important insights into understanding the implication of choline metabolism in developing
therapeutic strategies to treat PNS neuropathies.

Public health relevance
PROJECT NARRATIVE Peripheral demyelinating disease is a prevalent disorder of the PNS that affects myelin, and the prognosis of these diseases is poor with no available cure. Therefore, understanding the molecular mechanisms that regulate Schwann cell myelination and myelin repair is important for developing therapeutic strategies to improve the prognosis of the patients. Upon conclusion of the proposed study, we will 1) understand how choline, which is an important precursor to myelin membrane, is imported into Schwann cell, 2) understand how choline metabolism regulates Schwann cell myelination and 3) gain important insights into understanding the implication of choline metabolism in developing therapeutic strategies to treat peripheral demyelinating diseases.